Early Life Adversities and the Risk of Uterine Fibroids

Project Summary (Abstract):
The racial disparity in uterine leiomyomata (fibroids) is profound among Black/African American women (BW) –
with an earlier age of onset by 10-15 years, a significantly higher incidence, and greater rates of hysterectomy,
a major surgical procedure, compared to White women (WW). The impact of fibroids is significant for
reproductive age women, especially BW who experience more symptomatology such as excessive bleeding,
pain, and reproductive problems. Therefore, research on the risk factors for fibroids is important. Earlier onset
of fibroids among BW may explain their larger fibroid size and increased symptomatology. Our main
hypotheses are that exposure to adverse childhood events (ACEs) contributes to incident fibroids and greater
growth and that psychosocial resources may buffer the risk. We will use data from the National Institute of
Environmental Health Sciences Study of Lifestyle & Fibroids (SELF) that enrolled 1308 BW ages 23-34 years
without a clinical diagnosis of fibroids and collected extensive data at baseline and across 3 follow-up visits on
early childhood social and environmental factors, reproductive and sexual histories, and demographic,
economic, behavioral, and psychosocial factors. We will evaluate the hypotheses by pursuing three specific
aims: 1) Describe the prevalence ACEs occurring before age 12 by type, cumulative risk, and latent class
profiles, and examine the association between each ACE measure and childhood and adult contextual factors;
2) Describe each ACE measure in relationship to the trajectory of C-reactive protein (CRP); and 3) Examine
the association between each ACE measure and the incidence and growth of uterine fibroids, and then
evaluate the modifying effect of psychosocial resources. This proposed ancillary research study will elucidate
the association between ACEs and incident fibroids with less bias than previous research due to improved
ascertainment of both the exposure (i.e., 7 ACEs) and outcome (i.e., repeated and standardized ultrasound
exams in fibroid-free participants at study entry). Fibroids pose a major public health concern with an estimated
total associated cost (medical, work-related, etc.) of up to $34.4 billion annually. Determining risk factors for
fibroids, such as the early life stress of ACEs, will provide key information to improve the quality of life for Black
women, who are more likely to experience missed days from work and disruption in physical activities and
social relationships due to fibroids. It will also provide a strong research foundation that sheds light on potential
intervention targets to reduce morbidity and surgical disparities, set the stage for identifying biological
mechanisms for prevention, and elucidate the context of early life stressors on fibroid risk.

Public health relevance
Project Narrative: Uterine fibroids are common, contributing an annual estimated $34.4 billion financial burden. The risk of uterine fibroids is 2-3 times higher for Black women, and they are younger at diagnosis and have more symptoms than White women. Exposure to adversity during childhood may contribute to the development of uterine fibroids.